Trends and racial/ethnic differences in opioid prescribing safety and use of nonpharmacologic treatments for chronic pain in adults with co-occurring opioid use disorder

In the climate of increased opioid-related morbidity and mortality in the U.S., the safe, effective and
comprehensive management of chronic pain is critically important. People with comorbid chronic pain and
OUD and racial and ethnic minorities deserve specific attention due to their potential under-treatment of
pain and OUD, and elevated risk of adverse health outcomes. In 2016, the Centers for Disease Control
and Prevention (CDC) released a prominent clinical practice guideline that emphasizes non-opioid and
non-drug alternatives for pain management, and recommends safer prescribing practices if opioids are
prescribed to treat chronic pain. An examination of chronic pain treatment patterns over time and in
vulnerable subgroups of minorities and people with co-occurring OUD is needed to understand and
address health disparities in the delivery of guideline concordant treatment for chronic pain. Using 2015 to
2018 Medicare enrollment data combined with inpatient, outpatient and prescription claims data from a
20% national sample, the proposed research aims to: (1) assess racial and ethnic disparities in the types
of chronic pain treatments provided to people with comorbid OUD, and (2) evaluate whether the
implementation of the CDC guideline influenced racial/ethnic disparities in the treatment of chronic pain
for those with OUD. We will categorize pain treatments as pharmacologic, non-pharmacologic, and
combination of pharmacologic and non-pharmacologic. Among those prescribed opioids, we will assess
the guideline concordance of prescribing as it relates to opioid dosage and concurrent benzodiazepine
prescriptions. We hypothesize that racial/ethnic minorities with OUD are less likely to receive guideline
concordant opioid management and non-drug therapy than White chronic pain patients with OUD. We
further anticipate worsened disparities in chronic pain treatment following release of the CDC opioid
guideline. If confirmed, we will explore potential sources of disparities (e.g., co-prescribing of naloxone,
involvement of pain and addiction specialists) that could inform interventions to improve chronic pain
treatment in those with cooccurring OUD. The long-term goal of this research is to characterize and
reduce disparities in receipt of recommended standards of care and evidence-based treatment for people
with co-occurring chronic pain and OUD. Our findings will provide much needed evidence for more
effective and equitable public health and health insurance policy, and can inform future clinical guidelines.